A chromatin-based timer controlling T-cell development

PROJECT SUMMARY
During multicellular development, cells establish and maintain stable identities by activating lineage-specifying
genes. Epigenetic mechanisms, involving the polycomb repressive system and its associated histone H3
lysine 27 tri-methylation (H3K27me3) modification, are critical for proper cell lineage specification, and are
frequently disrupted in cancer; however, despite much work in many systems, it remains unclear how exactly
these histone modifications control gene expression, and how their disruption drives malignancy. These
questions remain unanswered, because we lack methods to follow epigenetic processes in living cells. We
recently developed a reporter system to analyze epigenetic control in the activation of Bcl11b, an essential
transcription factor for T-cell lineage commitment. To definitively test whether Bcl11b activation is controlled by
cis-epigenetic mechanisms acting at single loci, we generated a mouse, where two Bcl11b loci are tagged with
different fluorescent proteins (Ng et al. 2018). By following progenitors from these mice, we found that two
Bcl11b alleles turn on independently in the same cell, with one allele often turning on multiple days before
another. This work demonstrates that an epigenetic switch, acting independently on two Bcl11b loci, regulates
the dynamics of gene activation and T-cell commitment. Here, in this proposal, we seek to elucidate the
epigenetic mechanism controlling this lineage commitment switch, and determine impact of its disruption for
leukemia initiation. We will test the hypothesis that repressive H3K27me3 modifications uphold a key control
point for Bcl11b activation, and that disrupting this process can delay lineage commitment and drive leukemia.
To do so, we will first define the role for H3K27me3 loss in controlling Bcl11b activation (Aim 1). To do so, we
will perturb H3K27me3 modifications on the Bcl11b locus, and measure effects on locus activation dynamics.
In these assays, the dual-color Bcl11b reporter strain provides a powerful tool to visualize control by epigenetic
mechanisms in living cells. Next, we will determine how transcription factors work initiate H3K27me3 loss and
gene activation (Aim 2). To do so, we will perturb candidate TFs and cis-regulatory regions on the Bcl11b
locus, and determine resultant effects on H3K27me3 states and gene expression. Finally, we will determine
whether delays in differentiation, caused by disruptions of epigenetic mechanisms, drive leukemia initiation
(Aim 3). To do so, we will determine whether delayed Bcl11b activation slows down the pace of T-cell
development, and whether this developmental slowdown can accelerate the onset of T-ALL in a mouse model.
As polycomb mechanisms operate in diverse mammalian developmental processes, and because disruption of
these mechanisms may be a major driver of malignancy, our findings could broadly impact diverse fields.

Public health relevance
PROJECT NARRATIVE Epigenetic mechanisms, involving chemical modifications to the proteins that help package our genomes, help cells turn on the right genes at the right time to drive cell differentiation; yet, how they work to control gene activation remains unclear and widely debated. We seek to understand an epigenetic mechanism we recently discovered, that helps blood stem cells turn into a specialized cell type. Because mutations in these epigenetic mechanisms are major drivers of malignancy, these studies will yield broad insights into tumorigenesis across different cancer types.